CORE--SERVICE

The Administration an Service (A&S) Core contains the centralized administrative functions that are utilized by all 7 Research Components and the Pilot Projects. It also coordinates the activity of the PCR Genotyping Core. Oversight over training, animal production, and biostatistical analyses will be provided. Scientific oversight by the Scientific Advisory Board, review of Pilot Projects, and educational enrichment such as workshops will be managed by the A&S Core. The A&S Core will also oversee quality control mechanisms in all areas of Center activity. The A&S Core is structured to address 5 domains of activity. Each domain is under the direction of a Center PI. The A&S Core generally coordinates all Center activities, and administrative the budget. In order to group like functions in a sensible manner, and to facilitate the understanding of our budgeting principles, the budget for the A&S Core is subdivided into two parts. The first summarizes budgetary expenses related to administration, educational enrichment and dissemination, training, and biostatistical activity (Administrative Budget). The second maintenance (Animal Budget).